Temple University Gastroparesis Clinical Center

Abstract The Gastroparesis Clinical Research Consortium (GpCRC) focuses on the etiology, natural history, therapy of gastroparesis. The goal is to perform clinical, epidemiological, and therapeutic research in gastroparesis. Dr. Parkman is the principal investigator for the Temple site of the GpCRC with his NIH U01 grant, titled Temple University Gastroparesis Clinical Center This supplement will support the patient care costs related to these specific aims: First, recruitment and retention into our Gastroparesis Registry 3 of patients with symptoms of gastroparesis. Project Title: The NIDDK Gastroparesis Registry 3: Characterization and Clinical Course of Symptoms and Gastric Emptying in Patients with Symptoms of Gastroparesis. Second, recruitment and retention into our buspirone treatment study. Project Title: Buspirone for Early Satiety and Symptoms of Gastroparesis: A Multicenter, Randomized, Placebo-Controlled, Double-Masked Trial (BESST). Third, recruitment and retention into our proposed EndoFlip study of the pylorus. Project Title: Pyloric Sphincter Abnormalities in Patients with Gastroparesis Symptoms (PSAGS).

Public health relevance
PROJECT NARRATIVE Patients with gastroparesis often suffer with chronic gastrointestinal symptoms that are not adequately treated due to both a lack of understanding of the underlying causes and lack of effective treatments. The studies proposed by Temple University Gastroparesis Clinical Center for the NIH Gastroparesis Clinical Research Consortium will help improve the understanding, diagnosis, and treatment of patients with gastroparesis.